Kidney Support in Pediatric Patients using an Ultrafiltration Device

Abstract
In this Phase IIb grant, Koronis Biomedical Technologies (KBT) and its commercial and manufacturing
partner Nuwellis, Inc. propose to bring to market Vivian, a Continuous Renal Replacement Therapy
(CRRT) platform for treating critically ill pediatric and neonatal patients. In critically ill children,
especially neonates, acute kidney injury (AKI) and volume overload are common and associated with
significant morbidity and mortality. These patients require CRRT, but the large extracorporeal blood
volume (ECV) of current systems relative to patient body volume poses significant risks. Vivian will
address a market that is currently not served by any product, leveraging ultrafiltration technology to
yield an extra-low ECV, a critical enabling feature for this market segment.

Public health relevance
Project Narrative In critically ill children, especially neonates, acute kidney injury (AKI) and volume overload are common conditions that are associated with significant morbidity and mortality. The literature supports the need for a reduced extracorporeal volume continuous renal replacement therapy (CRRT) system for use in small children with AKI. A recent study evaluation of hemodynamic stability in neonates using traditional CRRT blood circuits shows that 55% of CRRT sessions had intradialytic hypotension, most of which occurred shortly after CRRT initiation.